Child Intervention, Prevention and Services Research Mentoring Network

This R‐25 application proposes a competing renewal of a multi‐site, interdisciplinary mentoring program in the field of child psychiatric intervention, prevention, and services (CHIPS). The CHIPS program targets post‐doc trainees and entry‐level faculty preparing to write their first NIMH career development or project grant in the area of intervention, prevention or services for child psychiatric disorders. It combines a one‐week summer institute with a minimum of one subsequent year of intensive mentoring and mentor‐guided expansion of the trainee’s professional network. The overarching goals of this program are to: (1) recruit and retain promising early career scientists to child and adolescent mental health intervention, prevention, and services research; (2) increase their success rate and decrease the time to successful acquisition of external funding; and (3) prepare researchers who can conduct research that spans the boundaries of intervention, prevention, and services research and that is strongly informed by advances in translational and developmental science. The one‐week summer institute strongly emphasizes experiential exercises and mentoring. It is focused on helping trainees acquire the full range of skills needed to prepare their next grant application. The CHIPS faculty have a record of successful mentoring and together span the breadth of intervention, prevention, and services research, and thus can promote the development of a broader training perspective to program participants than any single training site.

Public health relevance
Improved prevention and treatment of major psychiatric disorders in youth is a national priority. This R25 targets the critical transition of postdoctoral fellows and junior faculty without research grant funding to successfully funded researcher through a one-week Research Institute and subsequent year-long mentoring process. Our career development approach is based on the model of other successful Summer Research Institutes that target researchers studying adults and geriatric populations but modified to give greater emphasis on grant design and writing and greater time to small-group and one-on-one mentoring with many of the most senior researchers in this field.